Deep learning enabled, deep ultraviolet scanning microscopy for intraoperative assessment of margin status during breast cancer surgery

Women with positive margins after breast-conserving surgery (BCS) have a 2-fold increased risk of cancer
recurrence and are recommended to undergo additional re-excision surgery to achieve negative margins.
Additional surgery is associated with significant emotional, cosmetic and financial burdens for patients and their
caregivers. Although radiography, frozen section, touch prep and MarginProbe are available for intraoperative
margin assessment, their accuracy is variable and most, except radiographic examination, are time- and labor-
intensive and not routinely used. Since publication of the 2014 SSO-ASTRO guidelines for invasive cancer
recommending re-excision for positive margins only, the re-excision rates have decreased but remain substantial
(14-18%) with significant variation among surgeons. Because the size of BCS specimens varies significantly (a
few to >40 cm2 per margin) and positive margins often include one or multiple sites/foci, a device with both
variable margin coverage and microscopic resolution that can accurately evaluate an entire surgical specimen
within a few minutes is highly desirable. While new technologies have been proposed, they are either point or
high resolution devices with a very small field-of-view that requires excessive time to scan a specimen, or wide-
field devices with low resolution and poor sensitivity. None has demonstrated the capability of analyzing an entire
lumpectomy specimen with both adequate resolution and time efficiency in a clinical setting. Our goal is to
develop a deep learning (DL) enabled, deep ultraviolet (DUV) scanning microscope (DDSM) for subcellular
resolution and rapid (<5 min) examination of freshly excised tumor specimens during BCS. We hypothesize that
there are significant subcellular optical contrasts that can be identified by the DDSM to differentiate breast cancer
cells from normal tissue. Our preliminary DUV images demonstrate excellent contrasts and accuracy for
identification of breast cancer cells. We propose that large and variable margin coverage, microscopic resolution
and high speed are achieved by using: 1) DUV light for surface excitation of fresh specimens; 2) parallel imaging
of two margins; 3) a low optical manification for fast speed; and 4) DL and sparse-sampling (SS) to rapidly search
for pathological features of cancer cells. In Aim 1, a novel DDSM instrument will be developed and used to image
120 fresh breast tissues. DL classification algorithms will be developed and validated using the 120 tissue
samples in Aim 2. Aim 3 will integrate DL and SS algorithms into the DDSM and demonstrate for fast detection
of variable amount of cancer cells on the surfaces of breast tumor specimens. DDSM is highly innovative,
combining DUV microscopy, parallel imaging, DL classification, and SS in a fast, compact, automated design.
During initial BCS, if the DDSM accurately and efficiently identifies positive margins, additional breast tissue
would be removed from the surgical cavity until negative margins are achieved and unnecessary removal of
additional tissue would be avoided, thus decrease the need for additional surgery. DDSM is a platform technology
that can be used with other imaging modalities or adapted for detection of other cancer or noncancer conditions.

Public health relevance
PROJECT NARRATIVE Our long-term goal is to develop and implement a novel biophotonics imaging tool for intraoperative detection of positive tumor margins during breast conserving surgery. The imaging device we propose to develop will be practically designed and validated for use in a surgical setting. The imaging device is significantly relevant to public health in that it will significantly reduce the unnecessary additional surgery for women who undergo breast conserving surgery.